Repair of UV irradiated DNA: excision genes of yeast

Our long term objectives are to define the mechanisms of nucleotide excision repair (NER) in the yeast Saccharomyces cerevisiae. The specific aims of this proposal are: (1) to identify the components of E3 ubiquitin ligase and to identify the E2 ubiquitin conjugating enzyme required for RNA polymerase II (Pol II) degradation in response to DMAdamage. The components of Eld -associated ubiquitin ligase will be identified and the physical and functional interactions of the E3 components with one another and with the E2 enzyme will be analyzed by genetic and biochemical means. The ubiquitin conjugation reaction on Pol II will be reconstitutedfrom purified components; (2) to delineate the role of Rad7-Rad16-Elc1 protein complex in translocation of polyubiquitinated Pol II to proteosome for degradation. The physical and functional interactions of Rad7, Rad16, and Eld with Pol II and with the proteosomal subunits will be analyzed by genetic and biochemical means; 3) to identify the E2 and E3 enzymes required for Pol II monoubiquitination in response to DMA damage. Genetic studies will be done with mutations in these enzymes to reveal the physiological significance of this monoubiquitination event; (4) to determine the role of Psh1 in Rad6-Rad18 dependent histone ubiquitination and in chromatin remodeling during NER. The role of Rad6-Rad18-Psh1 complex in chromatin remodeling will be studied in biochemical experiments using a mononucleosomal DMA substrate containing a site specific DNA lesion and genetic studies will examine the role of these proteins in histone ubiquitination in responseto DNA damage in yeast cells; (5) to determine the role of Mms19 protein complex in NER and Pol II transcription. The role of this 4 subunit complex in NER and Pol II transcription will be studied by genetic and biochemical means; (6) to reconstitute NER on nucleosomal DNA. The NER system will be reconstituted on a mononucleosomal DNA substrate containing a site specific UV lesion and the role all the newly identified protein factors in NER will be determined. Defects in NER in humans cause the cancer-prone syndrome xeroderma pigmentosum and cells from patients with Cockayne syndrome, who suffer from severe growth and neurological problems, are defective in the repair of the transcribed DNA strand. We expect our studies in yeast to yield a comprehensive understanding of the underlying genetic bases of these human syndromes.